Harmonized Diagnostic Assessment of Dementia (DAD) for Longitudinal Aging Surveys in India (LASI)

Project Summary
The Harmonized Diagnostic Assessment of Dementia for the Longitudinal Aging Study in India (LASI-DAD)
is the first and only nationally representative and publicly available dataset on late-life cognition and dementia
in India. Our overarching goals are to develop a first rate, longitudinal study of late-life cognition and dementia
in India and to provide rich, high-quality data to the larger research community to advance our understanding
of risk factors of late-life cognitive decline and dementia. Further, we administer the Harmonized Cognitive
Assessment Protocol (HCAP), a common set of cognitive test batteries used by an international network of
researchers, enabling new and innovative comparative studies across both low- and high-income countries.
In this application, we aim to prepare for and collect Wave 2 of LASI-DAD. We will conduct follow up
interviews at Wave 2 with all Wave 1 respondents and also recruit newly age-eligible respondents. Using Wave
2 data, we aim to estimate the dementia incidence rate at the population level and to investigate its predictors.
We also aim to study cognitive changes and their correlates over the 4-year time period and to estimate the
economic and caregiving burden of dementia. LASI-DAD provides an unprecedented opportunity to study key
modifiable and non-modifiable risk factors for dementia and late-life cognitive decline. Rich, harmonized data
on cognitive tests and informant reports, as well as venous blood assays and geriatric clinical assessments,
enable cross-country comparisons of the influence of sociodemographic and biological variables (e.g.
cardiovascular, metabolic, and inflammatory factors) on late-life cognition and dementia.
For Wave 2,
we will further innovate by: (1) expanding our venous blood assays to include total and
phosphorylated tau protein in serum; (2) improving the measurement of personal exposure to PM2.5 using
mobile sensors and identifying the relative contributions of different air pollution emission sources; (3)
improving the hearing test protocol using an Android-based audiometry test; (4) assessing ocular health,
including the use of retinal fundus photography; and (5) assessing caregiving burden. Altogether, the findings
of the proposed investigation will yield new insights on the risk factors for dementia incidence and cognitive
decline, allowing a better understanding of potential targets for dementia prevention in India and other
countries around the world. As with Wave 1, we will prepare public use data and a codebook in a timely
manner and promote data usage through exhibits, training webinars, and a user help desk, actively building a
user base of researchers from across multiple scientific disciplines.

Public health relevance
Project Narrative This work will provide nationally representative data for estimating the incidence of dementia in India for the first time. Its rich and comprehensive data on modifiable and non-modifiable risk factors of dementia will enable all interested researchers to investigate the relative contributions of key risk factors of dementia, and the longitudinal nature of the project will provide insight on the deterioration of cognitive abilities among the aged over time. The generated data will also enable researchers and policymakers to determine the costs and burdens associated with providing care for older persons with dementia.